Biostatistics

ABSTRACT
The Biostatistics Core provides long-term collaborative support to established programs of research at
the Cancer Center, and short-term consulting services. The work of the Core enhances the scientific
objectives of the Center’s research programs by providing expertise on study design and statistical
analysis. The field of biostatistics is devoted to developing an understanding of the appropriate ways to
derive scientific inferences from quantitative data, and to developing methods for achieving this aim. The staff
is highly trained in this field and were all recruited after extensive national searches. The Core consists
of 22 doctoral-level faculty biostatisticians, assisted by four non-faculty doctoral level biostatisticians, 24
masters-level biostatisticians, and a team of programming staff and administrative staff. The faculty
biostatisticians in the Core have broad, collective experience in all of the specialized areas of statistical
techniques that are pertinent to contemporary cancer research, including clinical trials methodology, survival
analysis, epidemiologic methods, analysis of genomics data, statistical genetics, methods for
diagnostic medicine, evidence-based medicine and psychometric methods. Cost recovery is achieved
primarily through involvement of the Core members and staff as funded co-investigators on NIH grants. By
providing a valid framework for the design, conduct and analysis of scientific studies, the Core contributes to
scientific quality and promotes interdisciplinary research.